Real-time Internal Calibration for Multiplexed Microarray Analysis

DESCRIPTION (provided by applicant): There is a growing need for a highly efficient, simple, and easy to use quantitation method for multiplexed marker analyses. We hypothesize that differences in analyte flux to different addresses in a heterogeneous array-based platform can serve as an effective means to simultaneously determine the absolute concentration of a number of analytes with only the need to add a single calibrant to the sample. This proposal details a reduction to practice of technology that will afford a simple and cost-effective approach to determine the concentration of each marker - irrespective of the number of markers - without requiring the creation of calibration curves or the use of calibrants. The platform is extensible - meaning it could be deployed for genomic and metabolic studies as well as for platform proteomic assays - and could be applied to other readout methods.

Public health relevance
Breakthroughs in methodologies for calibration will prove pivotal as health care management begins to more strongly rely on multiplexed tests, placing a premium on sample consumption and throughput, labor, and material and reagent costs. This proposal details a reduction to practice of technology that will afford a simple and cost-effective approach to determine the concentration of each marker - irrespective of the number of markers - without requiring the creation of calibration curves or the use of calibrants.